RFA-CK-20-004: Prevention Epicenter of Emory and Collaborating Healthcare Facilities (PEACH II)

Our proposed research addresses healthcare-associated infections caused by multidrug-resistant
organisms (MDROs) across the healthcare spectrum from pre-hospital arena, into acute short-term
though long-term care facilities. We have capacity to engage in research activities at the largest
healthcare system in the Atlanta metropolitan area using Emory’s Clinical Data Warehouse, established
research ties to a multi-state network of nursing homes, and long-standing research collaborations with
other Prevention Epicenters, the Georgia Emerging Infections Program and Georgia Department of
Health. PEACH investigators have national recognition in MDROs and have contributed to the Prevention
Epicenters mission in the past. PEACH II will be advancing transdisciplinary research incorporating
human factors engineering, microbiome and environmental ecology, and informatics into transmission
interruption efforts, in a diverse spectrum of settings. We propose to advance the Prevention
Epicenter’s research mission through (1) engagement with a broad range of Emory and partner institute
scientists with expertise to contribute to Epicenter work, (2) collaborative observational and clinical
trials including study conduct, data use agreements, ethics approvals, and laboratory practices by
leveraging access to diverse (including underserved) patient populations across the healthcare
spectrum, and (3) expand collaborations with other Prevention Epicenters and Emerging Infections
Programs sites. Towards this latter aim, we are proposing four Core Projects: Core Project 1: InPART Rx
- Inpatient Provider Antibiotic Rate Benchmarking to Reduce Unnecessary Prescribing; T1: in Acute Care
settings, Priority Areas of Stewardship, decreasing AR infections; Core Project 2: FAIR – A clinical trial of
Fecal Microbiota Transplant for Antibiotic-Resistant Infections in Inpatients; T1 – in Acute Care settings,
Priority Areas: Decreasing AR infections, Understanding and decreasing transmission (source control,
environment), Regional control, Epidemiologically important pathogens in healthcare, Asymptomatic
colonization, and Microbiome; CORE PROJECT 3: PRE-ALERT - Predicting Admissions Likely Colonized
with Antibiotic Resistant Bacteria to Trigger Detection and Isolation; T-1: Acute care and Post-acute care,
Priority Areas of Regional control of AR; Innovative detect and response; Core Project 4: CHAMPIONS –
Collaborative Human Factors and Microbiology Approaches to Prevent Infections in Post-acute Care; T1:
in Long-Term Care, Priority Areas: Decreasing AR infections. Understanding and decreasing transmission-
environment; Regional control and long-term care facilities. Additional optional collaborative projects
target innovations around hand hygiene effectiveness multiple acute care settings, containment of
emergence resistance in long term acute care and nursing homes and improving sepsis management in
multiple pre-hospital settings.

Public health relevance
Public Relevance Statement. The Emory/PEACH epicenter will leverage national experts across diverse scientific disciplines at Emory University, Georgia Tech, and several other partnering institutions to inform and implement the scientific program of the CDC’s Prevention Epicenter, whose mission is to reduce antibiotic resistant infections across the spectrum of healthcare delivery. Clinical research proposed to occur in Atlanta includes in depth studies to find better ways to contain and eliminate the spread of superbugs aimed to have an impact across the region.